Defining Protective Responses in Hematopoietic Cells Mediated by STAT3 Anti-Inflammatory Activity

PROJECT SUMMARY/ABSTRACT
The hematopoietic system is the foundation of the inflammatory response. Hematopoietic stem cells and
multipotent progenitors (collectively termed HSPCs) residing in adult bone marrow generate inflammatory
myeloid and lymphoid populations. HSPCs also respond to pathogen-associated inflammatory stimuli by
adjusting the output of cells required to fight infection. HSPC activity is unfortunately co-opted in chronic
inflammatory conditions. These induce HSPC deregulation, loss of long-term stem cell repopulating function,
DNA damage, and myeloid-skewed hematopoiesis. In humans, chronic inflammation is linked with bone
marrow failure, myelodysplastic syndrome, and acute myeloid leukemia. An important gap in knowledge is how
the hematopoietic system is protected from the harmful effects of inflammation. By investigating this question,
we discovered a key role for the cytokine-activated transcriptional regulator STAT3; specifically, our results
suggest STAT3 anti-inflammatory activity is necessary to preserve HSPCs and lineage-balanced
hematopoiesis. We showed previously that STAT3 anti-inflammatory activity is mediated by transcriptional
repression of Ube2n, encoding Ubc13, an E2 ubiquitin-conjugating enzyme that activates TRAF6 and NF-
κB/MAPK signaling downstream of Toll-like receptors (TLRs) (e.g., TLR2, TLR4). We found hematopoietic-
restricted Stat3-deficiency leads to bone marrow failure, HSPC loss, myeloid-skewed hematopoiesis and
increased progenitor pro-inflammatory signaling. Strikingly, concomitant removal of Ube2n from Stat3-deficient
hematopoietic cells enables hematopoietic activity, suggesting STAT3 restraint of Ubc13 is required to
maintain functional HSPCs. Thus, we hypothesize STAT3 has a central role in protecting HSPCs from
inflammation-induced damage via modulation of Ubc13. To test this (Aim 1), we will investigate the role for
STAT3 in protecting hematopoietic function in inflammation. Using mixed bone marrow chimeras, we will
determine roles for STAT3 and Ubc13 in hematopoietic responses to inflammation; we will investigate STAT3-
activating cytokines and producer populations in bone marrow; and we will test the requirement for STAT3
transcriptional activity in HSPCs during inflammation using a transgenic strain expressing a transcriptionally
defective STAT3 mutant. In Aim 2, we will delineate molecular pathways by which STAT3 protects HSPCs
from inflammation-induced damage. We will determine roles for STAT3 and Ubc13 in protecting HSPCs from
DNA damage and loss of quiescence during inflammation, and we will determine STAT3- and Ubc13- genome-
wide transcriptional responses in HSPCs in homeostasis and inflammation. We anticipate this project will
provide unprecedented insight into intrinsic HSPCs protective mechanisms, fundamental information that will
move the field forward to an improved understanding of immune system regulation during inflammation.

Public health relevance
PROJECT NARRATIVE The goal of this project is to study a newly identified molecular pathway that suppresses inflammation and regulates balanced production of hematopoietic (blood) cell lineages. Unrestrained inflammation contributes to human health problems such as inflammatory bowel disease, autoimmunity and cancer, and has recently been connected to bone marrow failure due to loss of hematopoietic function. By understanding the molecular events that control inflammation and balanced blood cell production, we aim to learn how to better manipulate this response for improved disease treatments and enhanced human health.